Uncovering novel heme chemistry in microbial systems

Project Summary
In nature, metalloenzymes make up approximately one third of the known enzymes and play central roles
in biological processes such as photosynthesis, respiration, and nitrogen fixation. Heme-containing
metalloenzymes are particularly important in the context of energy conversion reactions due in part to their ability
to cycle between redox states. Furthermore, heme-containing enzymes can oxidize a broad range of substrates
in both a stereospecific and regiospecific manner, attracting interest for use in challenging chemical reactions
requiring C-H activation, C-C bond cleavage, or heteroatom oxidation. These enzymes are thus prime candidates
for biotechnological and synthetic applications, including production of pharmaceutical drugs, chemical
conversion of fatty acids and steroids, detoxification of drugs and toxins, and the synthesis of the industrially
relevant chemicals, fragrances, and flavors.
While heme proteins have been studied extensively, increasing amounts of genomic data have led to the
prediction of many additional heme, diheme, and multiheme protein families, of which the functional roles and
biochemical properties remain unexplored. Once such protein is MbnH, originally identified in methanotrophic
bacteria. MbnH is a member of the PF03150 bacterial cytochrome c peroxidase (bCcP)/MauG superfamily and
utilizes a rare bis-FeIV cofactor for the oxidation of a specific tryptophan residue within a partner protein, MbnP.
While other high-valent Fe states, such as compound I and compound ES, are relatively well understood, given
the limited biological examples of diheme bis-FeIV states, there is a fundamental gap in our understanding of
how nature stabilizes and uses bis-FeIV states without causing cellular damage. Nearly all previous research has
focused on MauG, limiting the generalizability of the role of the bis-FeIV species and the chemical capacity of
such an oxidant. Thus, the proposed research will leverage the huge amount of genomic information available
to expand the scope of studies on the bCcP/MauG superfamily. This includes representative members of the
annotated but uncharacterized protein families, SPOA0271 and TIGR3891, as well as new cluster identified by
the Enzyme Function Initiative Genome-Neighborhood Tool (EFI-GNT) tool as clusters 4 and 11. The broad
objective of this application is to establish how divergent bacterial diheme proteins stabilize high-valent bis-FeIV
states and then use that intermediates to accomplish site-specific substrate oxidation. It will address outstanding
questions related to the formation and stabilization of bis-FeIV, the catalytic capability of the bis-FeIV species, and
the biological role of this cofactor.

Public health relevance
Project Narrative This project will investigate new classes of diheme enzymes within a large superfamily that contains proteins predicted to use high-valent bis-FeIV intermediates for tryptophan oxidation. Specifically, it will focus on the formation and stabilization of the bis-FeIV state, as well as the biological use of this potent oxidizing intermediate. The results will elucidate new functions and mechanisms of diheme enzymes.